Molecular and Cellular Immunobiology

Project Summary / Abstract
We are seeking renewal of our long-standing training program in Cellular and Molecular Immunobiology to
continue providing cutting-edge predoctoral training that leads to a PhD in Immunology. Considering the latest
NIAID guidelines on training grant slot caps, combined with the ever-growing demand for access to our
predoctoral training program, we are requesting support for 8 predoctoral trainees in this renewal.
Our program offers comprehensive research training in the labs of Stanford immunologists, whose work spans
basic, computational, translational, and clinical immunology. A key focus of the program is systems analysis
within human immunology, equipping students to explore complex biological networks and apply integrative
approaches to understanding immune responses in health and disease. The curriculum emphasizes critical
thinking and the analysis of current immunological challenges, supplemented by seminars from leading
immunologists nationwide. Additional pillars include teaching opportunities, training in the responsible conduct
of research, and development of strong written and oral communication skills. Our predoctoral trainees are
drawn from a highly competitive and diverse applicant pool, recognized for their academic and research
excellence. The program prioritizes individualized advising and mentorship, with a flexible curriculum tailored to
meet the unique goals of each student. Students benefit from a stimulating, supportive training environment
and may choose between two curriculum tracks: the traditional Molecular, Cellular, and Translational
Immunology (MCTI) track, or the Computational and Systems Immunology (CSI) track, which integrates
computational and systems methodologies to enhance the understanding of immune processes at the systems
level. This interdisciplinary program unites a distinguished faculty from 21 departments across Stanford’s
medical school and university, supported by world-class resources and facilities. The success of the program is
demonstrated by the strong publication record of our trainees, their contributions to advancing immunological
research, and their leadership in diverse scientific careers.

Public health relevance
Project Narrative The Stanford Immunology training program aims to attract a diverse and talented cohort of predoctoral students, offering them advanced, cutting-edge education that leads to a PhD in Immunology. As the field of Immunology plays a critical role in understanding a wide spectrum of human diseases, the need for innovative and well-trained young immunologists is greater than ever. These future leaders will be essential in advancing fundamental knowledge of the immune system and driving the development of new diagnostics and therapies for immune-related conditions.